WHCOHH Community Engagement Core

Summary/Abstract
The overall objective of the Community Engagement Core (CEC) is to prevent human heath exposure to
harmful algal bloom (HAB) toxins by strengthening public and stakeholder knowledge about HABs and their
impacts, fostering collaboration among stakeholders and bi-directional dialogue with WHCOHH researchers,
and improving awareness of HAB issues in public health communities. The activities in this core are based on
the premise that communication and education through multiple mechanisms and to multiple interest groups
will improve awareness of HAB issues and management of resources, to the long-term benefit of public health.
Activities of the CEC will include the establishment of networks and infrastructure to facilitate and improve
information exchange and resource sharing among stakeholders concerned with the safety of marine
resources affected by HABs, including state, local, and Native American tribal managers, shellfish growers and
harvesters, and public health professionals. Our plans include the development of interactive web-based
mapping tools that will enable stakeholders to access, visualize, and interpret current and historical data
generated by WHCOHH and other HAB researchers, monitoring programs, and community groups. In
addition, we will strengthen and expand community and classroom education on the causes and impacts of
HABs by incorporating WHCOHH research into educational activities for K-12 students and teachers, and
engaging the public through a strong and multifaceted outreach program. To raise awareness of emerging
HAB issues within public health communities we propose to partner with well-established organizations that
provide fora for wide distribution and discussion of emerging issues in environmental health science. Ongoing
research will be shared as a result of our existing partnerships and by collaborating with community networks
to increase environmental health literacy. The WHCOHH CEC operates with the active participation of the
Project PIs and investigators, and with the CEC partners and organizations to engage a variety of stakeholders
and communities in the Northeast to prevent human heath exposure to HAB toxins. The CEC Leader will
facilitate interactions between stakeholders and WHCOHH investigators, and foster community engagement
and participation in our research at multiple levels.